Novel Vaginal Speculum for Decreased Patient Pain and Enhanced Provider Functionality in Outpatient Reproductive Care

Abstract
The vaginal speculum is an essential tool in gynecology that has a role in almost every procedure or exam in
an outpatient setting. Traditional speculums have significant failings, such as patient pain and discomfort
during use. Additionally, limitations for providers can cause procedures to be challenging and potentially more
uncomfortable for the patient, especially patients with complicating factors such as obesity or existing
conditions. Out of fear or anxiety of pain and discomfort, patients avoid seeking out care, especially those
marginalized by prior history of trauma, sexuality, and race or ethnicity. Yona Care is developing a speculum
that decreases patient pain and discomfort. For providers, the Yona speculum improves functionality with better
field of view, greater tool access, and streamlined operation, all of which flatten the learning curve. Within the
scope of work funded by an NIH SBIR grant, the Yona team will use a human-centered engineering process to
develop and assess the speculum against user-driven emotional and performance objectives. During the
engineering portions, the team will optimize the form and range of motion to minimize patient discomfort and
maximize provider field of view, as well as develop lighting, locking, and material decisions. Prototypes will
then be created to conduct bench testing to evaluate the engineering, including using pressure distribution as a
proxy for pain. During the research portion, Yona’s clinical partner will invite patients and providers to handle
and interact with the models in an interview setting to assess the impact that the Yona speculum would have
on patient behavior and provider workflow. By developing a tool that improves the patient experience and
augments the capabilities of the provider, the speculum can reduce the challenges and barriers to long term
care outcomes, access, and adherence. In the US alone, roughly 69.4 million speculum exams are performed
each year. At the individual level, an average patient may experience over 30 speculum exams or procedures
in their lifetime, each of which has an unquantifiable emotional impact. For these patients, each interaction with
a speculum could determine whether they actively seek out care in the future or if they allow fear, anxiety, and
avoidance to shape their relationship to reproductive health. Patients who have fear and anxiety of the pain
and discomfort of a speculum may avoid preventative care that could reveal treatable conditions, delay
treatment when they are ill or experiencing abnormal symptoms, or make life-changing decisions about
reproductive care based on pain-avoidance behavior rather than their actual needs. By improving the
speculum, Yona Care can positively impact the health and experience of each individual who requires
speculum-based care and can affect positive change at the public health level by reducing barriers,
encouraging care adherence/seeking behavior, and mitigating the financial, resource, and wellness costs of
delayed or avoided care.

Public health relevance
Narrative Yona Care is developing a speculum that decreases patient pain and improves provider functionality in order to reduce the barriers for quality, consistent, and accessible care. In the US, 69.4 million speculum exams are performed annually, which means that on average, each person in the US who requires speculum-based care might experience more than 30 exams or procedures in their lifetime. Beyond the numerical impact, the emotional and behavioral impact of each exam is incalculable, and patients who have better experiences are more willing to actively pursue and get preventative care when recommended, get treatment more promptly when there are issues, and make decisions around reproduction and sexual health with fewer limitations.